IOWA PERSIAN GULF RESEARCH PROJECT: FOLLOW UP STUDY ON ASTHMA

The purpose of this study is to compare the true rate of confirmed disease among samples of Persian Gulf War military personnel with and without self-report of asthma, versus true rate of confirmed disease among samples of non-Persian Gulf War military personnel, with and without self-report of asthma. The study will also identify risk factors for asthma including medical and family history, psychological factors, and occupational and environmental exposures for validated illness.